Defining DNA resection and protein localization changes that occur during DSB repair

Project Summary/Abstract—R35 PARENT GRANT
DNA double strand break (DSB) repair pathways resolve DNA lesions that arise during cellular
metabolism or as the by-product of cell damage. Human DSB repair pathways fall into two
distinct categories: end joining (EJ) pathways that rejoin the DSB molecule, and homology
directed repair (HDR) pathways that use a template molecule to repair the DSB molecule. The
factors that cells use to decide between EJ and HDR repair pathways remain incompletely
defined. Many studies have shown that the cell cycle regulates DSB pathway choice, yet
cultures arrested at points in the cell cycle that favor HDR still repair the majority of DSBs using
EJ. The long-term goal of the research in my lab is to comprehensively define factors that bias
DSB repair in sufficient detail that we can predict DSB repair outcomes based on the initial
conditions inside a cell. Pursuit of this goal will improve our understanding of DNA repair and
related processes, enable new generations of gene editing reagents with greatly increased
efficacy, and suggest new strategies to diagnose and treat human DNA repair pathologies,
including cancer and aging.
Over the next five years, we will develop a holistic model for DSB repair that describes DNA
repair events occurring on the DSB and template molecules. Our goals in generating this model
are to define the irreversible commitment step between EJ/HDR and to understand if cells
sense their capacity to perform HDR before they pass commitment. These are important
challenges for the cell, because inappropriate HDR can cause cell death or genomic instability.
We hypothesize that cells have the heretofore unmeasured ability to develop DSB repair
complexes in parallel, and that parallel maturation of DSB repair complexes plays a role both in
the EJ/HDR commitment and as a checkpoint for these repair pathways. Parallel development
of EJ and HDR complexes either on the DSB molecule or split between the DSB and template
molecule would allow cells to simultaneously develop different types of repair before committing
to one or the other. The ability to generate mature repair complexes prior to commitment would
make DNA repair substantially less risky. Our practical approach is to develop genomic and
proteomic techniques that allow us to measure DSB repair intermediates with unprecedented
temporal and spatial resolution. We will use these techniques to define how protein complexes
associate with chromatin over time and, crucially, the strandedness of DNA bound to DSB repair
proteins. Measuring this latter parameter will allow us to determine when events occur in
relation to the EJ/HDR decision and thus understand when and how this decision is made. We
also explore mechanisms of communication between multiple DSB repair complexes assembled
in parallel onto chromatin. Parallel events are especially informative because they indicate a
dynamic system in which cells simultaneously explore multiple DSB repair pathways, thereby
preserving choice until repair is nearly complete. For example, events on the template molecule
may act as a checkpoint for events on the DSB molecule, or vice versa.
This work will enable new tools that leverage our understanding of DSB repair to influence gene
editing outcomes and to improve therapeutic workflows. We also anticipate that our work will
open new fields of inquiry, for example defining how DSB repair complexes assembled interact
with each other and with cell-wide signaling mechanisms.

Public health relevance
Project Narrative—R35 PARENT GRANT The goal of this proposal is to understand how cells repair one type of DNA lesion, the double strand break (DSB). DSB repair is essential for a broad range of cellular processes from DNA replication to innate immunity, while dysregulated DNA repair is a hallmark of cancer and other human diseases. Research described in this proposal will increase our understanding of a fundamental biological process and may improve gene editing and chemotherapy.